New win methods for addressing multiple and composite outcomes in cluster-randomized trials

Project Summary/Abstract
Cluster-randomized trials (CRTs) offer a powerful experimental design to evaluate the impact of complex
interventions in medicine and public health, and have become among the most common study designs for
embedded pragmatic trials seeking to improve patient care. Unlike individual-randomized trials, CRTs
randomize intact clusters of subjects to alternative conditions, resulting in correlated observations that require
specialized inferential tools. To maximize the patient-centered information gleaned from CRTs, there is an
increasing interest in investigating the net treatment effects defined through win estimands (net benefit, win
ratio, win odds) on multiple—prioritized and non-prioritized—outcomes that capture benefit or risk. However,
existing statistical methods in CRTs have been primarily developed to address a single outcome measure.
Principled methods that leverage the power of win statistics to guide the analysis of multiple and composite
outcomes in CRTs are sparse, and their formal development requires addressing several methodological
challenges. First, CRTs present a multilevel data structure that necessitates clear definitions of estimands.
However, the existing estimands in CRTs do not address pairwise comparisons with multiple outcomes.
Second, while covariate adjustment is a promising technique to improve estimation precision with a single
outcome, robust and efficient covariate adjustment methods when targeting win estimands in CRTs remain
under-developed, leading to missed opportunities in optimizing trial efficiency. Third, there is a lack of
regression tools that enable the association analyses between win parameters and covariates when multiple
outcomes collected from different individuals are correlated. To overcome these challenges, we will develop a
suite of novel methods using clustered win statistics by maximizing information extraction from both covariates
and outcomes, and apply our new methods to several CRTs that assess electronic health record alerts
interventions for patients with heart failure. In Specific Aim 1, we will leverage the semiparametric efficiency
theory of U-statistics to develop model-robust and efficient covariate-adjusted win estimators in CRTs with
multivariate outcomes. In Specific Aim 2, we will expand the covariate-adjusted win estimators to censored
time-to-event outcomes, and capitalize on the dual role of covariates in simultaneously addressing censoring
bias and improving efficiency. In Specific Aim 3, we will develop marginal win regression methods to study the
associational effects of covariates on win fractions under cluster correlated data, when the outcomes are either
quantitative, or censored time to event. In Specific Aim 4, we will develop open-source software packages,
tutorial papers, case studies, and short courses for all proposed methods, and use the NIH Pragmatic Trials
Collaboratory as a unique national channel for effective dissemination. This work promises to advance the
knowledge gained from past and future CRTs with complex outcomes by substantially expanding the toolbox
for addressing win estimands in the multilevel data setting.

Public health relevance
Project Narrative Although there is an increasing interest in investigating the net treatment effects defined through win estimands (net benefit, win ratio, win odds) on multiple and composite outcomes in cluster-randomized trials, existing developments of win statistics assume independent data and cannot be directly applied, representing a huge lost opportunity for cost-efficient evidence generation through embedded healthcare intervention studies. To overcome these limitations, we will develop a suite of novel methods using clustered win statistics that maximize information extraction from both covariates and outcomes, and apply our new methods to reanalyze several cluster-randomized trials assessing electronic health record alerts interventions for patients with heart failure. This work promises to advance the knowledge gained from past and future cluster-randomized trials with complex outcomes by substantially expanding the toolbox for addressing win estimands in the multilevel data setting.